Ultra-low distortion and noise electronics to enable a clinical MPI imaging platform

SUMMARY/ABSTRACT
In this SBIR grant proposal, “Ultra-low distortion and noise electronics to enable a clinical MPI imaging platform,”
we will develop the RF subsystem for a clinical magnetic particle imaging (MPI) platform to enable three classes
of MPI applications: cell tracking, functional imaging, and endogenous contrast imaging. Our overall approach is
to improve sensitivity and resolution by minimizing distortion, adding transmit/receive channels, decoupling,
improving preamplifiers, and developing new pulse sequences.
MPI is an emerging molecular and tracer imaging technology that directly detects magnetic nanoparticles
(MNPs) with high sensitivity at mm-scale resolutions. MPI images are direct views of tracer distribution with no
signal arising from tissue, no perturbations from materials such as air, and image intensity directly linear with
tracer concentration. This “hot-spot” contrast provides spatial localization and quantification without ambiguity.
MPI’s contrast is similar to nuclear medicine but without the workflow, safety, and half-life limitations of a
radioactive tracer. MPI has many applications in the brain and body, as demonstrated by our customers in small
animals. Despite significant efforts by multiple institutions, the lack of a clinical MPI scanner remains a significant
limitation for the technique.
In this Direct to Phase II SBIR proposal, we will advance the medical imaging field by building the world’s
first general-purpose clinical MPI scanner to serve the myriad applications our customers are testing on our
preclinical instrument. We will design and implement a new transmit/receive subsystem and install it in our
prototype scanner to achieve the performance necessary for clinical imaging applications. This new
transmit/receive subsystem includes the following innovations that push our sensitivity from our current rough
prototype to near the physics limit through the following specific aims:
Aim 1. Drive transmit distortion and the noise floor to the physics limit for a one-channel Tx/Rx coil
Aim 2. Design a clinical multi-channel transmit and receive subsystem
Aim 3. Develop new acquisition pulse sequences to improve sensitivity, resolution, and speed

Public health relevance
NARRATIVE Despite the importance of medical imaging in modern clinical diagnosis and treatment, current techniques struggle in essential areas such as monitoring newly developed cell-based therapies, detecting diseases of inflammation, and quantitatively detecting bleeding. Magnetic Particle Imaging (MPI) is an emerging medical imaging technology that provides scientists and clinicians with a new tool for understanding, diagnosing, and monitoring these pathologies. In this Direct-to-Phase II SBIR grant, we will develop critical technologies to bring the sensitivity and resolution of the world’s first human-scale MPI scanner near the physics limits, marking a significant step forward on the path to a commercial clinical MPI scanner.